Administration Core

ADMINISTRATIVE CORE
SUMMARY
The mission of the Administrative Core is to support and promote the scientific and collaborative goals of the
QCRG Pandemic Response Program. The Core will provide leadership that ensures strong oversight and
representation of all stakeholders in decisions and facilitates the integration of Research Projects and
Technology Cores. Day-to-day activities will be coordinated by the Center Director (Dr. Nevan Krogan), who
has extensive experience leading and managing large research centers, and the Administrative Core Co-
Investigators (Drs. Lorena Zuliani-Alvarez and Manon Eckhardt). They will be supported by the UCSF
Quantitative Biosciences Institute (QBI) administrative team. Evaluation of progress toward the Center’s goals
as well as budgeting and long-term planning of center activities will be performed by the Executive Committee
(EC), consisting of the Director and Drs. Melanie Ott, Kevan Shokat and Brian Shoichet. The EC will
communicate progress to our commercial partner, Roche, and meet with regulatory advisors once a year. As a
first task of the Executive Committee (EC), a Scientific Advisory Board (SAB) will be formed to review progress
of the program and future plans. The Administrative Core will be responsible for managing QCRG Consortia
with support of the QBI Finance Team. Supported by the QBI Media and Events team, the Administrative Core
will organize and manage a number of regularly scheduled meetings for the EC, the entire QCRG, and the wider
research community to facilitate communication amongst members and scientific exchange, as well as maintain
the QCRG website and shared file servers. To provide formal site review and involvement with NIAID staff, the
Core will organize an annual SAB Meeting, in which the PIs and key personnel will meet with the SAB and NIAID
program staff to review the Center’s activities. The Administrative Core will further design, solicit and manage
the Developmental Research Project and Mentored Project programs to adapt the Center’s goals to emergent
technologies and scientific advancements, attract new Investigators, and support early career QCRG scientists.